Improving Palliative Measurement Application with Computer-Assisted-Abstraction Study

Background: VA needs to incorporate the Veteran and family voice in measuring performance, and it may
improve care to involve Veterans and families more deeply in improvement. This is especially true for
palliative and end of life care, given the 30% of lifetime Medicare costs in the last year of life, and the
divergent perspectives that Americans have expressed regarding end of life care. We have identified major
gaps in VA performance, but work is needed to prioritize indicators from the Veteran and family
perspective and to improve measure feasibility. The latter will foster better VA quality and experience of
care and facilitate monitoring the potential impact of paid, non-VA care on seriously ill Veterans.
Aims: The Improving Palliative Measurement Application with Computer-Assisted-Abstraction Study
(ImPACS), will prioritize measures and operationalize a subset of higher, intermediate, and lower feasibility
process and utilization measures for palliative and end of life cancer care. We aim to:
Aim 1: Solicit priorities from two Delphi panels - one of Veterans and families and a second of experts
regarding process and healthcare use quality measures for advanced cancer care, including which of the
42 Cancer Quality ASSIST measures to extract, and conduct interviews regarding how to integrate
Veterans and families in VA measurement and improvement for palliative and end of life cancer care, and
Aim 2: Extract high priority process and utilization measures using natural language processing of VA
charts and administrative data and in a sample drawn from Stanford and Dana Farber’s Healthcare's
Epic systems, focusing on the domains of pain and opioids, mental health, and goals of care
communication, and
Aim 3: Examine associations of the extracted measures with Veteran characteristics, focusing on
disparities in the care of rural and nonwhite Veterans and palliative care use.
Methods: For Aim 1, we will recruit two Delphi panels - one of Veterans, family members, and a second of
expert stakeholders. Veteran-family members will have experience with cancer. Experts will have expertise
in the methods and application of quality measures. Purposive sampling will focus on critical attributes
(e.g., race) that may affect priorities. Panelists will rate and rank measures within tiers of high,
intermediate, and low feasibility, informed by reviews of the evidence for intervention and impact of
performance gaps on patients and caregivers. We will also interview Veterans, family members and VA
leaders at high and low performing VA facilities based on the Bereaved Family Survey of end of life
experience, to see how deeper Veterans-family involvement might strengthen quality and experience of
end of life care. For Aim 2, we will operationalize a subset of prioritized process measures from Aim 1
including Cancer Quality ASSIST measures using natural language processing of text notes and machine
learning. In Aim 3, we will characterize variation in measures with Veteran characteristics focusing on
known disparities among rural and nonwhite Veterans and palliative care services use.
Impact: We will produce Veteran and family-informed priorities for a balanced measure set for palliative
and end of life cancer care. We will inform how Veterans and families might be more deeply engaged in
fostering improved quality and experience and fostering a learning healthcare system. Finally, we will
extract prioritized measures using state of the art methods to improve their feasibility, characterize
variation at the Veteran level focused on known disparities and palliative care potential to mitigate them.

Public health relevance
The study will benefit Veterans by identifying a patient and family centered balanced set of quality measures of palliative and end of life cancer care to inform VA operations as well as further research. The study will prioritize indicators to extract, and that will become candidates for routine VA use, on the basis of direct patient and family input. In doing so, the study will set a standard for VA quality measurement in general; furthermore, it will create generalizable information on how Veterans and families can be more directly involved at the facility level as participants in quality measurement and improvement of palliative and end of life cancer care. ImPACS will characterize variation in quality measures prioritized by patients and family members to also show where VA can take action to improve care in response to Veteran and family priorities with a focus on disparities among rural and nonwhite Veterans.